Manipulation of antibody responses by a retrovirus

Abstract
Following exposure to antigens, naïve B cells differentiate by going through germinal center reaction
into plasma cells or memory B cells. Plasma cells secrete antigen-specific antibodies which aid in the
clearance of invading pathogens by direct neutralization, by activating the complement cascade or by
interacting with other immune cells by binding to Fc receptors. Long lived memory B cells can be reactivated to
differentiate into plasma cells following secondary infection. Together, memory B cells and long-lived plasma
cells form the basis for life-long B cell-mediated protection against various infections. To evade host protective
immunity all successful pathogens have evolved numerous mechanism to directly or indirectly manipulate B
cells. Pathogens could manipulate B cells by using them as a reservoir, by interfering with B cell maturation
and by modulating B cell survival. Mouse mammary tumor virus (MMTV) is an exogenous retrovirus which
persist indefinitely in mice of susceptible strains. B cells represent the primary and indispensable target for this
virus and yet persistently infected mice do not make significant titers of virus-neutralizing Abs. Unlike mice from
MMTV-susceptible mice I/LnJ mice even though become virus-infected produced potent virus-neutralizing Ab
responses leading to the virus elimination. Using a positional cloning approach, we discovered the negative
immune regulator of the major histocompatibility class II (MHCII) peptide presentation, DO is dysfunctional in
mice from the I/LnJ strain and its dysfunction is a sole reason why these mice generate virus-neutralizing Ab
responses.
DO is a non-classical Major Histocompatibility Class II (MHCII)-like molecule which has evolved as a
negative regulator of yet another MHCII-like molecule, DM. DM catalyzes peptide loading of MHCII on antigen
presenting cells (APCs) for presentation to CD4 T cells. In the absence of DO there is a significant increase of
high-affinity peptides presented by MHCII as DM is uninhibited. Whereas naïve B cells express high levels of
DO, DO is downregulated during generation of Ab responses to allow for presentation of high affinity peptides
and entering the germinal center reactions. We hypothesis that non-lytic viruses that infect B cells prevent
downregulation of DO in germinal center B cells to avoid presentation of high affinity virus-specific peptides.
The studies described in this basic science proposal will determine whether a B cell infecting retrovirus, such
as MMTV impedes the mechanisms controlling DO levels in germinal center B cells to prevent the
development of isotype switched, virus-specific Ab responses.

Public health relevance
Project Narrative This proposal will determent whether viruses infecting B cells block anti-virus responses by interfering with the major histocompatibility class II presentation pathway.